Multisystem Stress Response Biotypes: Deriving Novel Physiological and Neural Risk Factors for Anhedonia in Adolescence

PROJECT SUMMARY
Anhedonia (ANH), the reduced ability to anticipate or experience pleasure, is a major transdiagnostic contributor to
disability, poor quality of life, and a core characteristic of multiple severe psychopathologies. ANH emerges in
adolescence prior to the onset of these disorders and is highly prevalent (up to 20%) in youth 13-15 years. However, ANH
in adolescence is poorly understood and interventions remain few. A growing body of evidence suggests that stress
exacerbates ANH and dysregulated acute stress response mechanisms may critically contribute to ANH. Yet, little is
known about the role of stress neurobiology in the emergence, course, and severity of ANH in adolescence, a critical
developmental period marked by significant pubertal changes and steep maturation of neural circuits implicated in the
recalibration of the stress-response systems and mood regulation. The objective of the current proposal is to characterize
how acute biological stress response mechanisms influence the severity and trajectory of ANH. ANH research to date has
almost exclusively focused on single-system physiological responses to acute stress, such as autonomic nervous system
(ANS - parasympathetic and sympathetic nervous system branches - PNS-SNS) or endocrine (HPA - Hypothalamic
Pituitary Adrenal)) system responses. New evidence supports the need for multi-system approaches to detect clinically
meaningful patterns of stress responses associated with ANH. Recent research from our labs (PI Belger and Co-PI
Roubinov) has shown that (1) discrete physiological latent stress response profiles (Buffered, Vigilant, Sensitive) that
integrate unique patterns of responses across HPA and ANS systems have additional utility in predicting both clinical and
functional development outcomes beyond single-system biomarkers. In this proposal, we will examine how a novel
constellation of complex neurobiological stress response mechanisms interactively contributes to ANH in adolescence.
Using a multimodal approach including functional MRI (Magnetic Resonance Imaging), physiological HPA and ANS
stress reactivity, and clinical and cognitive assessments, the proposed study will be the first to integrate physiological and
neural acute stress response mechanisms to derive multisystem stress response biotypes (MSRB) and explore their
contributions to ANH severity and trajectory in adolescence. We will study 192 adolescents ages 13-15 years
experiencing a range of ANH at baseline, 10 months, and 20 months across 2 Aims. In Aim 1 we will identify
multisystem stress response biotypes (MSRBs) integrating physiological and neural responses to acute stress in
adolescents and examine their longitudinal stability. In Aim 2, we will determine the characteristics of multisystem latent
stress profiles that predict the severity and trajectory of ANH in adolescence. Across both aims, we will examine age, sex
and pubertal stage as covariates.
IMPACT: This project will contribute a novel framework for understanding and modeling the complex multisystemic
biological mechanisms governing stress responsivity during adolescence. Understanding the individual and interactive
contributions of physiological and neural systems to ANH presents a unique opportunity to develop specific interventions
that target malleable stress systems in adolescents with ANH.

Public health relevance
PROJECT NARRATIVE Anhedonia, the inability to anticipate or experience pleasure, emerges in adolescence, often heralds the onset of more severe psychopathology such as mood disorders and psychosis, and remains poorly understood. Atypical stress responseS and related dysregulation of neurobiological mechanisms have been proposed as key contributors to anhedonia. The proposed project will examine the individual and interactive roles of physiological and neural mechanisms associated with acute stress experiences to the severity and maturational trajectory of anhedonia in adolescence, thereby potentially informing the development of novel prevention and intervention strategies